METHYLPHENIDATE PLUS CHOLINERGIC MEDIATION OF P50 AUDITORY SENSORY GATING

The purpose of this study is to assess whether nicotine ameliorates methylphenidate-induced impairment of auditory sensory gating.